Rapid Three-dimensional Simultaneous Knee Multi-Relaxation Mapping

PROJECT SUMMARY
Osteoarthritis (OA) is one of the most prevalent diseases affecting human joints, characterized by decreased
proteoglycan content and disruption of the collagen fiber network in the cartilage extracellular matrix. Magnetic
resonance (MR) imaging has been used to quantify cartilage composition and microstructure changes due to
degeneration in OA. Among all MR techniques, MR relaxometry is the most popular and can provide non-invasive,
high-resolution, three-dimensional imaging biomarkers, which would be highly valuable in quantifying human
tissues. Cartilage spin-spin (T2) relaxation time has been found to be sensitive to the changes of collagen
ultrastructure associated with early cartilage degeneration. Cartilage spin-lattice relaxation in the rotating frame
(T1ρ) is sensitive to the concentration changes of macromolecules and is correlated with proteoglycan loss in
OA. The role of spin-lattice relaxation (T1) time has also been reported to correlate with the mechanical property
changes of cartilage and is sensitive to progressive damage of the tissue. While each relaxation parameter
provides limited and complementary information of cartilage, the capability of imaging T1, T2 and T1ρ together
would provide a set of comprehensive imaging biomarkers for synergistically accessing the macromolecular
content and their ultrastructure of cartilage. However, due to long scan time, poor image acquisition efficiency,
and complex image reconstruction and tissue modeling, simultaneous multi-relaxation mapping is very
challenging thus remains underdeveloped in OA research studies. This proposal will provide rapid three-
dimensional simultaneous multi-relaxation imaging for mapping T1, T2, and T1ρ of the knee through developing
a novel imaging sequence and reconstruction method (Aim 1). This new technique will leverage efficient three-
dimensional golden-angle image acquisition and will be accelerated through a novel deep learning method that
leverages self-supervised learning and MR physics-informed tissue modeling. The derived MR imaging
biomarkers will be correlated with cartilage histological, biochemical, and mechanical properties, which will
create a basis for interpretation of the clinical study results (Aim 2). A pilot clinical study using the optimized and
accelerated imaging technique will be performed on patients with varying degrees of knee OA, establishing the
clinical evidence of the utility, efficiency, and overall clinical value of multi-relaxation mapping on detecting and
staging OA (Aim 3). Our proposed new methods will root from developing novel rapid image acquisition,
combined with advanced deep learning reconstruction and automatic processing, all of which are pioneered by
our team. Successful completion of the proposal will offer a new rapid imaging technique to non-invasively
monitor disease-related and treatment-related changes in tissue composition and ultra-structure through multi-
relaxation assessment. It will have broad clinical applications for OA and other diseases.

Public health relevance
NARRATIVE This proposal will develop a rapid multi-relaxation imaging technique that can provide simultaneous three- dimensional T1, T2, and T1ρ relaxation mapping for quantifying tissue composition and ultra-structure using magnetic resonance imaging. The imaging technique incorporates a novel multi-relaxation mapping sequence using 3D golden-angle rapid acquisition and a novel physics-informed deep learning reconstruction and will be evaluated in a knee disease model. Our novel proposal would provide a new rapid imaging approach to non- invasively monitor disease-related and treatment-related changes in tissue composition and ultra-structure through multi-relaxation assessment and will have broad clinical applications for various diseases.